Osteoclast to Osteocyte Crosstalk in Accelerated Bone Turnover

PROJECT SUMMARY/ABSTRACT
This proposal comprises a five-year research and career development program for Dr. Diana Athonvarangkul to
achieve independence as an investigator in disorders of bone and mineral metabolism. Dr. Athonvarangkul is a
physician-scientist who completed her training in an NIH-sponsored Medical Scientist Training Program. The
proposed research and career development activities will occur at Yale University. To facilitate her goal of leading
her own independent research group, she has developed a training program based on high-yield didactics and
professional development opportunities with support from a dedicated mentoring committee comprising
scientists with a broad range of expertise relevant to the proposal and an impressive record of mentorship. She
has laid out a clear timeline for these activities with timing of subsequent publications and acquisition of funding.
The combination of research and career development plans described in this proposal will allow the candidate
to mature into a successful and independent physician-scientist.
Osteoporosis affects 10 million Americans and leads to 2 million broken bones each year. While a great deal is
known about the molecular pathways by which osteoclasts remove bone, relatively little is known about how the
most abundant cell type in bone, the osteocyte, remodels bone. Osteocytes remove bone from their surrounding
matrix in a process known as osteocytic osteolysis. Our laboratory established that during lactation, osteocytic
osteolysis is the physiological response to increased maternal calcium demand. The focus of this proposal is to
elucidate mechanisms regulating osteocytic osteolysis using a lactation model, with an emphasis on how the
osteoclasts and osteocytes coordinate their resorbing activities. Aim 1 will interrogate whether osteoclastic bone
resorption influences a phenotypic switch in which osteocytes upregulate osteoclast-like gene programs and
enlarge their lacunae and canalicular network. Aim 2 will follow up on previous observations to determine
whether the lactational hormone, parathyroid hormone-related peptide (PTHrP), stimulates production of
Receptor Activator of NFB Ligand (RANKL) to activate osteocytic osteolysis. Aim 3 will evaluate whether
transforming growth factor beta (TGF) is a coupling factor released by osteoclast activity that regulates
osteocytic osteolysis by interacting with PTHrP/PTH1R signaling. Aims 1 and 2 of this proposal will allow Dr.
Athonvarangkul to gain experience and proficiency in the approaches needed to study bone biology. Aim 3 will
facilitate the discovery of new molecule(s) and communication pathways among bone cells. As an independent
investigator, Dr. Athonvarangkul will use the skills acquired in this proposal to determine how communication
between osteoclasts and osteocytes is disrupted in diseases with excess bone loss. The experiments presented
in this proposal will provide a new mechanistic understanding of intercellular communication within the bone
environment during reproduction and may identify new therapeutic targets for the treatment of osteoporosis.

Public health relevance
PROJECT NARRATIVE This study focuses on how osteoclasts direct osteocytes to remove bone using lactation as a model. A better understanding of how osteoclasts communicate with osteocytes to coordinate bone metabolism will expand our knowledge of pathways that lead to excess bone loss. With the knowledge gained from this study, we ultimately may be able to design new, more efficacious agents to target the abundant osteocyte for treatment of osteoporosis.